Development of a novel method for cannulation in pediatric cardiac procedures

Project Summary
The goal of this proposal is to develop a quick-connect cannulation system to allow rapid, easy, and safe
cannulation in pediatric cardiac patients. Extracorporeal membrane oxygenation (ECMO) has emerged as a
vital tool for saving patients suffering cardiovascular and/or respiratory failure. However, even in well
experienced hands, the initiation of ECMO support is relatively time consuming in a stressful environment with
frequent complications.
The goal of this R21 proposal submission is to develop a novel quick-connection cannulation system to
allow for rapid, easy, and safe cannulation in the pediatric population. This proposal is being submitted to PA-
18-482 after discussion with NICHD program officers. We will accomplish this through two specific aims.
Aim 1: Develop new rapid cannulation device. A new rapid cannulation device will be developed and
prototyped. The device will be designed to securely attach to current commercial arterial and venous cannulas
from 8Fr-16Fr in diameter and tested for mechanical stability on a tensile testing machine.
Aim 2: Evaluate device in bench top and swine animal tests. The device will first be evaluated in a bench
test using 3D printed model hearts and a closed loop pressurized system to mimic cardiac flow. Once these
tests are successful, swine animal trials will be done using expired pigs from other research projects at our
institute.
The successful completion of this project will provide us with a prototype device that can move towards
clinical studies in future work, which would include developing a biodegradable version. An alternative safe,
easy, and fast cannulation procedure may reduce the duration of E-CPR by minimizing the time needed for
secure cannulation, reducing or even preventing potential damage to the brain and other organ systems. Such
an innovation has the potential to significantly improve outcomes both in terms of mortality and morbidity of
pediatric patients undergoing E-CPR.

Public health relevance
Project Narrative In this project we will develop a new technique for quickly connecting the tubing to route the blood through the heart during pediatric cardiac surgery. The new technique should help minimize the operating time and as such would be an improvement in the current standard of care.